IGF::OT::IGF RESEARCH, DEVELOPMENT, MANUFACTURE OF CLINICAL MATERIALS, AND CLINICAL TESTING OF VACCINES TO PROTECT AGAINST ZIKA VIRUS

IGF::OT::IGF RESEARCH, DEVELOPMENT, MANUFACTURE OF CLINICAL MATERIALS, AND CLINICAL TESTING OF VACCINES TO PROTECT AGAINST ZIKA VIRUS